Beyond PheWAS: Recognition of Phenotype Patterns for Discovery and Translation

Project Summary
Genomic medicine offers hope for improved diagnostic methods and for more effective, patient
specific therapies. Genome-wide associated studies (GWAS) elucidate genetic markers that
improve clinical understanding of risks and mechanisms for many diseases and conditions and
that may ultimately guide diagnosis and therapy on a patient-specific basis. The previous two
cycles of this effort (2011-2014 and 2014-2018) introduced the phenome-wide association study
(PheWAS) as a systematic and efficient approach to identify novel disease-variant associations
and discover pleiotropy using electronic health records (EHRs). This proposal will develop novel
methods to identify associations based on patterns of phenotypes using a phenotype risk score
(PheRS) methodology to systematically search for the influence of Mendelian disease variants
on common disease. By doing so, it also creates a way to assess pathogenicity for rare variants,
and will identify patients at highest risk of having undiagnosed Mendelian disease. The project is
enabled by large DNA biobanks coupled to de-identified copies of EHR. This project has four
specific aims. First, we will develop and validate PheRS for assessment of variant pathogenicity
by leveraging billing codes, laboratory data, and NLP features in its predictive algorithms. The
second aim is to apply PheRS in huge populations to create a robust repository of rare variant
associations in diverse populations (eMERGE Network and large national cohorts, which could
approach 2 million people with genotype data). The third aim is to assess Mendelian disease
penetrance and evaluate PheRS as a tool to identify patients at risk for undiagnosed Mendelian
disease. The fourth aim is make these tools and resources broadly available to aid in variant
interpretation and facilitate others running PheRS. The tools generated from this project will
validate new approaches to interpreting the function of rare variants, improve basic
understanding of Mendelian disease, greatly enhance our understanding of the contribution of
Mendelian disease variants to common disease and traits, and offers a potential approach to
identify subpopulations of patients for whom new therapies may offer benefit.

Public health relevance
Project Narrative Genomic medicine offers hope for improved diagnosis and for more effective, patient- specific therapies. This Phenotype Risk Score (PheRS) proposal, built on the prior PheWAS methodology, provides a systematic approach to search for patients with inborn genetic diseases in the electronic health record data and identifies those at highest risk of having undiagnosed diseases. The PheRS method not only has enormous potential to inspire and inform translational science, it also has the potential to impact general practice medicine in a clinical setting.